Innate Immunity Stimulation Effects on Biomarkers, Cognition, and the Vascular Amyloid Proteome in a Squirrel Monkey Model of Sporadic CAA

PROJECT SUMMARY
Dysregulation of innate immunity is thought to be a significant contributor to Alzheimer’s disease (AD)
pathogenesis. We have focused on harnessing innate immunity via Toll-like receptor 9 (TLR9) to modulate age-
related defects in immune cells to counteract AD pathology. Our findings from multiple AD pathology transgenic
mouse models provide the first in vivo evidence that stimulation of innate immunity with TLR9 agonist CpG ODN
can reduce behavioral deficits and ameliorate all pathological hallmarks of AD. Most current immunotherapeutic
trials for AD have been associated with a major complication referred to as amyloid-related imaging abnormalities
(ARIA), which is linked to the presence and extent of cerebral amyloid angiopathy (CAA). CAA is present in a
majority of individuals with AD, and its severity is an independent risk factor for cognitive decline. Hence, it is
critical to develop a therapy effective against CAA without inducing ARIA complications. Additionally, the
premature translation of promising transgenic mice data directly to patients has been associated with a very high
clinical trial failure rate. Our recent study established that squirrel monkeys (SQMs), an NHP model that develops
extensive age-dependent CAA unlike other primates, represent an opportune environment for demonstrating the
therapeutic benefits of our immunomodulation using CpG ODN 2006. Here we propose the use of class B CpG
1018, which is currently being tested in clinical trials for a variety of indications. The collective studies are
designed to provide a comprehensive portrayal of CpG 1018 efficacy and long-term safety by integrating biofluid
biomarker signatures with imaging markers, cognitive measures, in addition to neuropathology correlates.
Disease progression and safety will also be monitored by a combination of MRI techniques, which will enable
morphometric characterization and screening for ARIA. The utility of a multi-shell diffusion MRI model to follow
CpG 1018’s treatment effects in vivo on brain microstructural integrity, especially WM integrity changes, will be
validated for the first time. An additional strength of this proposal is the use of our powerful proteomic strategy
to unveil the first comprehensive characterization of the CAA and choroid plexus (CP) proteomes in association
with disease progression and CpG 1018 intervention. This localized proteomic approach is a preferred method
as it combines unbiased mass spectrometry examination with laser capture microdissection to precisely excise
defined neuropathological lesions. A further aim of this study is to map involvement of the CP-CSF system in
immune cell trafficking in response to CpG 1018. Delineating the CAA and CP protein signatures will advance
understanding of CpG 1018’s favorable immunomodulatory capabilities, as well as provide insights into CAA
pathogenesis to improve diagnostic capability. Overall, the interventions described here will provide
essential preclinical evidence that will enhance CpG 1018’s potential for clinical application.

Public health relevance
NARRATIVE Recent clinical trials for Alzheimer’s disease have faced high failure rates in part due to a poor translation of preclinical findings from studies completed in transgenic mice, and immunotherapeutic trials in particular have been impeded by significant complications linked to the clearance of cerebral amyloid angiopathy (CAA). This proposal will utilize TLR9 agonist CpG ODN 1018 to stimulate innate immunity, and represents the first comprehensive evaluation of CpG ODN 1018 efficacy and safety in squirrel monkeys, a non-human primate model with a predilection for age-associated CAA, by integrating biofluid biomarker data with imaging markers and cognitive measures, in addition to post-mortem neuropathology correlates. The study will also feature advanced multi-shell diffusion MRI models to follow whole brain and white matter microstructural changes in response to treatment, and will conclude with an in-depth characterization of the CAA and choroid plexus proteomes using our group’s innovative localized proteomic strategy, which altogether will provide essential data advancing CpG ODN 1018’s feasibility for clinical application, as well as promote further discoveries of CAA diagnostic biomarkers.